Dynamic Acellular Materials for Repairing Dense Connective Tissues

Abstract
Dense musculoskeletal tissues, such as the meniscus, are plagued by poor healing. Meniscal tears disrupt load
transfer in the knee and instigate more widespread degenerative and inflammatory processes. Unfortunately,
there are no current treatment options that restore meniscus function and joint homeostasis. To address this, we
developed an injectable (shear-thinning) bicontinuous hydrogel that can be delivered in a minimally invasive
manner to a meniscal tear to promote rapid colonization by cells. This hydrogel, composed of gelatin and
hyaluronic acid (HA), exhibits unique microinterfaces with a high interfacial surface area that allows for rapid cell
infiltration from adjacent tissue. Beyond a material that can be delivered to the damaged meniscus and supports
subsequent cellularization, meniscus repair strategies must also address the physical and biological
impediments to healing. We previously identified nuclear mechanics as a key impediment to meniscus cell
migration and transiently reduced nuclear stiffness (using the histone deacetylase inhibitor trichostatin A, TSA)
to enable rapid endogenous cell migration. We also found that inflammation present in the joint post-injury
reduced meniscus cell migration, and that this could be reversed by applying FDA-approved interleukin
antagonists (IL1ra). To deliver these factors, we developed a novel class of mechano-activatable microcapsules
(MAMCs) that enable efficient encapsulation and staged release of sensitive biologic factors. In this renewal, we
combine these exciting biomaterial (Aim 1) and drug delivery (Aim 2) advances to translate an innovative
injectable hydrogel platform that concomitantly releases factors to enable cell migration, quell inflammation, and
promote matrix production via controlled delivery in a load bearing joint setting. We test this novel therapy in
vivo, in our large animal meniscus injury model (Aim 3) in the setting of established joint disease. Our overall
hypothesis is that injectable bicontinuous materials coupled with mechanically activatable delivery of pro-
migratory and anabolic agents will improve meniscus repair after injury. The proposed studies build on over 15
years of collaboration by our team of engineers and clinicians on the development of implantable and injectable
biomaterials for meniscus injury. If successful, this work will provide a novel therapeutic material designed to
treat meniscus tears that are otherwise considered irreparable, restoring joint health to the millions of patients
with meniscal injuries.

Public health relevance
Narrative Menisci of the knee cushion our joints during normal loading but are commonly injured. Unfortunately, healing of menisci in adults is limited, and current treatments do not restore function, resulting in degeneration of the underlying cartilage and progressive joint disease. To address this, we engineer injectable biomaterials with tailored biofactor release to sequentially promote cell migration from surrounding tissue and direct matrix formation upon arrival at the injury site, and test these in a clinically relevant large animal meniscus repair model.